Enhanced treatment of breast cancer via biodegradable polymer nanoparticles

ABSTRACT
Breast cancer remains the second largest cause of cancer related deaths in the USA. Heat shock protein
(HSP) inhibition has emerged as a promising target to treat breast cancer. However, the drawback of these drugs
is cardiotoxicity. Nanoparticle delivery of HSP inhibitors should avoid this side-effect, as well as increasing
delivery of drug to the tumor. Various types of nanoparticles can also enhance the effects of photothermal therapy
on cancer killing. Moreover, photothermal therapy together with delivery of HSP inhibitors is a potent combination
treatment. However, many of the types of nanoparticles typically used in photothermal therapy are not well-suited
for drug delivery, are very slowly excreted, are expensive, are challenging to scale up and are synthesized using
toxic reagents or organic solvents.
We herein propose a novel polyphosphazene nanoparticle (PPNP) to treat breast cancer via enhancing
photothermal therapy and delivering a HSP inhibitor. The PPNP will be also loaded with ultrasmall silver sulfide
nanoparticles that provide strong photothermal therapy enhancement, but when released from the biodegradable
nanoparticle, are rapidly renally cleared. The silver sulfide nanoparticles also provide contrast for multiple
imaging techniques (i.e. computed tomography, mammography, photoacoustics and fluorescence), thereby
allowing delivery to be assessed and guiding laser irradiation. This is a low cost platform that is synthesized by
microfluidics, which enables large scale synthesis of a homogenous product. These PPNP will be synthesized,
characterized, and tested for their contrast production. Drug loading and release will be assessed, as will their
enhancement of photothermal heating. Breast cancer killing will be studied in vitro and in vivo. We will also
perform in vivo imaging, as well as safety and clearance studies. Overall, we expect to develop a potent new
tool for the treatment of breast cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE Despite advances in the treatment of breast cancer, a significant number of tumors grow back, which can lead to the need for more treatments or mortality. We herein propose to develop a new drug treatment that, when combined with laser irradiation, should better prevent tumor recurrence and result in better outcomes for patients.